Hedgehog signaling in adult bone and cartilage homeostasis

Hedgehog (Hh) signaling is required for the differentiation of mesenchymal progenitors into osteoblasts during endochondral bone formation. However, the role of Hh signaling in differentiated osteoblasts during adult bone homeostasis remains to be elucidated. In addition, Hh signaling is also required to control chondrocyte proliferation and hypertrophy. In the past year we found that in the postnatal bone, Hh signaling activity has to be tightly regulated. Abnormal activation of Hh signaling in the bone leads to tumor-like lesions.